Development of an intraoral device for therapeutic drug monitoring of anti-epileptic drugs

PROJECT ABSTRACT
Saliva is the ideal biofluid for therapeutic drug monitoring applications in general, and specifically for
continuous monitoring because it is amenable to measurement noninvasively within the oral cavity. The
development of an intraoral device for the continuous real-time monitoring of anti-epileptic drugs in saliva could
enable the promise of precision medicine and advancing optimal dosing for each individual. In this project, we
will demonstrate feasibility of our proposed intraoral sensor platform by coupling capillarity-based microfluidics
and electrochemical detection to ultra-low-power readout electronics, and to use a machine-learning-based
approach for offline processing of sensor data, to create an intraoral sensor for the real-time quantification of
therapeutic drug levels in saliva in the presence of variation of salivary pH, temperature, and other common
confounders. The intraoral sensor will consist of a reusable, comfortable electronics module that will fit
securely into the patient’s mouth, and that interfaces with a disposable microfluidic chip containing
voltammetry-based detection. The intraoral sensor electronics module will communicate wirelessly with a
mobile device that will process the data and display and relay drug levels semi-continuously and in real time.

Public health relevance
PROJECT NARRATIVE For people with epilepsy and their caregivers, the challenge of controlling severe disease symptoms such as seizures, while also minimizing adverse drug side effects, is exacerbated by the large inter-individual pharmacokinetic variability and drug-drug interactions of often-prescribed therapeutic drugs. We propose to develop a wearable retainer-like oral device that would enable real-time, multi-time point monitoring of therapeutic drug levels, wherever an individual is located. We will use an innovative strategy in which we couple capillarity-based microfluidics and low-power electronics with state-of-the-art signal analysis, as combining these emerging technologies is crucial for creating a device that could advance precision medicine and enable optimal therapeutic drug dosing for each individual.